Molecular Basis of Mitochondrial Dysfunction in Neurodegeneration

Alzheimer's disease is the most frequent form of dementia that is characterized by progressive memory loss and cognitive dysfunction. Mutations in presenilins are the most common cause of early onset familial Alzheimer's disease. Although altered presenilin function has been known to have a role in Alzheimer's disease for more than 20 years, the functional consequences of mutations in presenilins are controversial and not understood. Due to the complexity in understanding presenilin function, we are using a simple model system, Caenorhabditis elegans, to uncover the in vivo biological role of presenilins. We have discovered that mutations in sel-12, which encodes a C. elegans presenilin ortholog, leads to increased transfer of endoplasmic reticulum calcium to the mitochondria, which results in a concomitant increase in mitochondrial respiration and superoxide production. Furthermore, we have demonstrated that the neurodegeneration that develops in sel-12 mutants is caused at least in part by this increase in mitochondrial superoxide production. We hypothesize that presenilin mutations lead to increased endoplasmic reticulum – mitochondria contact and communication that results in altered mitochondrial function that negatively impacts neuronal health. We will take a multifaceted approach to test this hypothesis. First, we will define the role presenilin and calcium have in mediating endoplasmic reticulum – mitochondria interaction dynamics. Second, we will determine the role mTOR signaling has in promoting neurodegeneration in presenilin mutants. Third, we will determine the role presenilin mutations associated with familial Alzheimer's disease have in mitochondria function and neurodegeneration. Lastly, we will identify key gene products that help mediate the elevated endoplasmic reticulum to mitochondria calcium transfer observed in presenilin mutants. Knowledge gained from the study of presenilin function in C. elegans should provide novel insight into the mechanisms underlying Alzheimer's disease and may lead to novel therapeutic strategies for treating Alzheimer's disease.

Public health relevance
Project Narrative Deregulation of mitochondrial function is implicated in most if not all neurodegenerative diseases. The goal of this project is to resolve the molecular mechanisms underlying the role presenilin, which is implicated in Alzheimer's disease, has in mitochondrial function and cellular health.w